Community Engagement Core

The Community Engagement Core (CEC) within the Southwest Environmental Health Sciences Center
(SWEHSC) is integral to developing and maintaining the relationships that allow SWEHSC to meet its mission
of determining the human health impacts of environmental exposures among people living in arid environments.
The CEC facilitates multidirectional and culturally-anchored engagement between SWEHSC researchers, the
National Institute of Environmental Health Sciences, and Southwestern educators, public health professionals,
community members, and policy makers. The SWEHSC is in the arid Southwest, a region that is home to
communities living in understudied environmental conditions that include exposures to unique toxicants. Primary
health concerns in these communities include cancer, diabetes, autoimmune diseases, reproductive disorders,
and respiratory disease that can result from exposures to extreme heat, airborne pollutants, pesticides, forest
fire smoke, dust storms, and drinking water contaminants such as per- and polyfluoroalkyl substances and
arsenic. The CEC vision is to combine respect for Indigenous science, traditional ecological knowledge, “funds
of knowledge,” and citizen observation/inquiry with modern scientific advances to engage Southwestern
communities and to design materials and programs to work towards improving environmental health. The CEC
applies this vision through four aims: 1) using multi-directional communication strategies to assure that SWEHSC
investigators address the environmental health (EH) issues of greatest concern impacting our target
communities; 2) ensuring the dissemination of key research findings to our target communities so that they may
better protect their health; 3) advancing community engagement through our risk and safety communication
model and report-back strategies to ensure that these communications effectively promote public health; and 4)
increasing capacity by training the next generation of EH scientists from these communities. In realizing these
aims, the CEC equips the next generation of EH scientists with the necessary engagement skills and scientific
knowledge to address environmental health issues affecting the desert Southwest populations.